Bright IDEAS-Young Adults: Problem-Solving Skills Training to Reduce Distress among Young Adults with Cancer

Project Summary/Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
24-041: Administrative Supplements for Assessing and Enhancing Survivorship Care.” The goal of this proposed
supplement is to examine the extent to which survivorship care for young adults (ages 18-39) with cancer aligns
with the recently developed National Standards for Survivorship Care and to identify barriers and facilitators for
obtaining high-quality survivorship care in this group. Young adults with cancer have unique emotional, social,
and practical needs relative to other age groups due to the intersection of cancer treatment and normal
developmental processes. The transition from cancer treatment into survivorship follow-up care can be
challenging for young adults. In particular, the delivery of survivorship care is often fragmented and there is a
lack of coordination between providers who are often not even in the same health system. Existing data indicates
that young adult survivors report persistent unmet practical, emotional, and social needs that negatively impact
their quality of life many years into survivorship. The parent award aims to address the diverse and extensive
needs of young adults newly diagnosed with cancer by evaluating a problem-solving skills training intervention
called “Bright IDEAS-Young Adult” (Bright IDEAS-YA). This intervention provides a skill to effectively manage
the stressors of cancer care. The aims of the parent award aims are to evaluate the efficacy of the Bright IDEAS-
YA on psychosocial outcomes, determine the extent to which problem-solving ability mediates treatment effects,
and explore moderators of treatment effects (i.e., sex, financial strain, unmet needs, baseline distress). A total
of 344 young adults with cancer were enrolled in the parent award and are being followed for two-years post-
enrollment. The ultimate goal is to improve quality of life outcomes for young adults with cancer. This proposal
is consistent with the aims of the parent award and logically extends the work to understand the transition to
survivorship care and its impact on young adults’ quality of life. This proposed supplement offers a very timely
and meaningful opportunity to fill an identified gap in cancer survivorship research by gathering rich qualitative
data from young adults at the time of their transition into survivorship care, rather than retrospectively recalling
the transition. The aims of the supplement are to determine the extent to which survivorship care for young adults
aligns with the National Standards for Survivorship Care and to identify barriers and facilitators for obtaining
high-quality care. The approach will include mixed methods, conducting in-depth interview to supplement survey
data among a subset of participants enrolled in the parent trial. Results will guide future intervention development
tailored to address the unique survivorship care needs of young adults.

Public health relevance
Project Narrative The delivery of survivorship care for young adults (ages 18-39) with cancer is often fragmented and poorly coordinated, resulting in suboptimal care and leaving these young adult survivors with persistent unmet needs. This supplement will leverage a fully enrolled clinical trial evaluating a psychosocial intervention to improve quality of life outcomes for young adults with cancer to examine how early survivorship care aligns with the National Standards for Cancer Survivorship Care and identify barriers and facilitators to obtaining high-quality care. Results will inform future interventions tailored to the needs of young adults with cancer to enhance survivorship care and quality of life outcomes.